Robotic Augmentation of Physical Therapists for Locomotor Rehabilitation

PROJECT SUMMARY
This project seeks to transform locomotor rehabilitation with telerobotic systems that lessen the physical
demands on therapists but preserve their ability to dynamically tailor therapeutic strategies using their clinical
expertise and intuition. This capability could improve the quality and efficacy of robotic therapy—a significant
need, given the lack of solid evidence that traditional robotic approaches surpass conventional methods in
improving patient outcomes, particularly in locomotor rehabilitation. We address this need by leveraging
telerobotics to augment therapists' capabilities in applying their specialized skills for manipulating movement to
promote sensorimotor learning in patients. The project is structured around two aims designed to address critical
gaps in understanding how physical therapists adapt their manipulative forces and provide assistance during
treadmill locomotion, both during hands-on therapy and with telerobotics. In Aim 1, we enroll 40 physical
therapists who manually assist a randomly assigned treadmill walker with an artificial neuromuscular
impairment created by gait event-triggered electrical stimulation to the hamstrings of one leg. We measure the
forces therapists exert and develop a model that describes how therapists adjust their assistance during
locomotor training. Aim 2 extends this investigation to a telerobotic context, where the therapists assist the
artificially impaired walkers using a small robotic manipulator that mimics the actions of a larger robot attached
to the walkers, allowing therapists to remotely feel and assist the walkers in achieving different functional goals,
yet with less effort because the telerobotic system amplifies the effects of the therapists' manipulative actions.
We hypothesize that the manipulative strategies therapists employ will be effectively translated through the
telerobotic system, demonstrating no significant difference from their hands-on approach. This research is an
essential step toward determining the practicality and effectiveness of telerobotic systems in physical
rehabilitation. The project will provide valuable insights into the dynamics of physical manipulation and its
translation through robotic systems by directly measuring and modeling therapist manipulative strategies in
both traditional and telerobotic settings. Additionally, the outcomes of this study could significantly impact
clinical practices by offering a viable option for remote rehabilitation, particularly benefiting patients in rural or
underserved regions who lack easy access to specialized care facilities. The integration of telerobotics into
rehabilitation has the potential to transform the therapeutic landscape by reducing physical strain on therapists,
enabling more precise and controlled interventions, and opening new pathways for delivering high-quality care
remotely. Ultimately, this project aims to lay a foundational understanding that will guide the future design of
rehabilitation robots and the development of therapeutic strategies, improving the quality of life for
approximately 10 million Americans living with neurological injuries.

Public health relevance
PROJECT NARRATIVE This project investigates whether physical therapists can effectively apply their expertise using telerobotics to manipulate patient locomotion, compared to traditional hands-on methods. Motor adaptation models will be used to quantify therapists' manipulative strategies to understand how they physically interact with patients and how this interaction is affected by robotic technology. This research will provide critical insights into enhancing the quality and accessibility of rehabilitation services for individuals with neurological impairments, potentially transforming treatment paradigms and improving outcomes for millions.